Translational Research Core

TRANSLATION RESEARCH CORE: PROJECT SUMMARY
The Center for American Indian and Alaska Native Diabetes Translation Research (CAIANDTR) offers
resources locally, regionally, and nationally to advance a translational research agenda specific to AI/ANs, but
generalizable to other segments of the population—in particular racial/ethnic minorities and rural populations.
Its Translation Research Core: 1) Provides training, technical assistance, and consultation activities, delivered
through a Research Base of funded faculty -- drawn from the UC/AMC, but in this renewal expanded to sister
universities through an innovative network of Satellite Centers -- whose research either targets diabetes or is
translational in nature with clear potential for application to diabetes; and 2) Emphasizes community outreach
and engagement, with special attention to enhancing participant recruitment and retention; the cultural
adaptation of diabetes prevention and treatment interventions to improve effectiveness; health literacy
measurement and the development as well as evaluation of related materials and methods; health information
technologies that promote surveillance, increase patient knowledge, improve adherence to treatment
recommendations, and enhance compliance with standards of care; dissemination and implementation
science, notably individual, provider, and organizational factors that affect the diffusion and adoption of
evidence-based practices, programs, and policies related to diabetes prevention and treatment; and
sustainability that emphasizes the cost of caring for diabetes and related conditions, and that informs the
structure and financing of related services. The Translation Research Core rigorously evaluates the impact of
these activities on the capacity of other investigators to pursue scientifically meritorious diabetes translation
research specific to AI/ANs.